Design of de novo interleukin mimics for targeted immunotherapy

PROJECT SUMMARY
Although immunostimulatory cytokines can be used to combat cancer, their poor stability and high off-target
toxicity has limited their application in the clinic. The ​long-term goal of this project is to produce targeted
anti-cancer cytokine mimetics with reduced toxicity. The ​overall objective is to apply recent breakthroughs in ​de
novo protein design to yield a new category of targeted, non-toxic, immunostimulatory proteins. The ​central
hypothesis is that the beneficial stimulatory effects of natural cytokines can be engineered into ​de novo
designed proteins which do not engage in off-target binding, thereby circumventing the dose-limiting toxicities
seen in clinical applications of natural/reengineered cytokines. The ​specific aims are to: (1) use ​de novo protein
design to generate hyperstable, bioactive mimetics of interleukin-2, -4, -12, -15, and -21 which function by
engaging with (i.e. binding to) interleukin receptors ​in vivo​; (2) to split these mimics into inactive parts which
can regain activity by reassembling ​in vivo​; and (3) to fuse each of these inactive parts to specific targeting
domains, thereby yielding conditionally-active cytokine mimics that stimulate T-cells by reassembling only on
the surface of a targeted cells (i.e. cancer cells displaying two specific surface biomarkers). ​As proof of
principle​, the first such ​de novo designed cytokine mimetic has been produced, split, and shown to reduce
tumors in mice without accompanying toxicity or immunogenicity. This research proposal is ​innovative because
it seeks to resolve a long-standing barrier to cancer immunotherapy (namely, the off-target toxicity of
cytokine-based therapeutics) by designing from scratch a new class of non-toxic cytokine mimics. The
proposal is ​significant because it would be the first example of computational protein design yielding targeted,
biosuperior cancer therapeutics. Ultimately, such molecules have the potential to treat a wide range of cancers,
including malignant melanoma, renal cell carcinoma, and more.

Public health relevance
PROJECT NARRATIVE The proposed project is relevant to public health because it seeks to develop a new class of targeted, non-toxic cancer therapeutics. Computational protein design will be used to generate novel protein immunotherapeutics that mimic the activity of natural cytokines but with enhanced therapeutic properties. Thus, the proposed project aligns with the NIH’s mission to reduce illness and disability.